Extracellular regulation of Xenopus development

Project Summary
Vertebrate embryo body plan is established through cell-cell interactions driven by a small
number of signaling pathways. The knowledge of these embryo-derived molecules and
pathways has been instrumental for in vitro differentiation of mouse and human pluripotent
stem cells and serves as a basis for tissue engineering. In amphibians, signaling from Wnt,
BMP, FGF and Nodal-related ligands results in the formation of the Spemann organizer and
subsequent tissue patterning. Many other extracellular factors regulate the time, location
and level of these signaling events, and their discovery and analysis remain an important
goal of basic developmental biology. This application focuses on the analysis of pinhead
(pnhd), a conserved gene that we identified in a screen for Wnt target genes.
Overexpression and depletion experiments suggest roles of pnhd in axial patterning, but its
mechanism of action is currently unknown. Other preliminary studies show that Pnhd is a
secreted protein that modulates Wnt- and BMP-dependent signaling in a region-specific
manner. Based on this evidence, Pnhd is hypothesized to function as a new context-
specific modulator of embryonic pathways. The proposed experiments will test this
hypothesis by characterizing the developmental roles and functional effectors of Pnhd that
are relevant to vertebrate axis specification and anteroposterior patterning. Other studies
will address the molecular basis of the context-dependent effects of Pnhd on Wnt signaling.
The mechanism of Pnhd action will be investigated using Xenopus embryos, in which
biochemical and cell biological approaches can be combined with rapid functional analysis
in the context of an intact animal. These studies will contribute to further understanding of
signaling networks leading to body plan specification and patterning during early
development. Since Wnt and BMP pathways have been implicated in many human
cancers, the proposed experiments will unravel novel molecular mechanisms that operate
during normal embryonic development and become frequently disrupted in disease.

Public health relevance
This application concerns molecular analysis of conserved signaling pathways regulating body axis specification and patterning in developing vertebrate embryos and relevant to cancer. The proposed studies will contribute to the understanding human disease origin and will help design new drugs and therapies.